ANGIOTENSIN II MODULATION IN ESSENTIAL HYPERTENSION--QUINAPRIL AND CAPTOPRIL

To determine the contribution, if any, of vasodilating prostaglandins to the blood pressure lowering effect of converting enzyme inhibitors in salt-replete, renin-dependent hypertensive man.